Summer Undergraduate Program in Emory Renal Research (SUPERR)

Project Summary
The Summer Undergraduate Program in Emory Renal Research (SUPERR) will promote
an appreciation for the study of kidney, urology, and hematologic (KUH) diseases among
undergraduate students who are interested in furthering their scientific research and could be
encouraged to pursue a career in biomedical scientific research. Early exposure of
undergraduate researchers to these exciting areas of study will give promising students first-
hand experience in laboratory methods to answer questions that directly affect human health
and disease. Our goal is to foster sustained interest in KUH diseases, thereby increasing the
number of students applying to PhD, MD/PhD, and MD programs, and increasing the cadre of
scientists in the biomedical workforce studying these topics in the future. SUPERR will expose
undergraduate students to current questions in KUH diseases that are being investigated by
NIDDK supported investigators at Emory University. Following a national recruitment, selected
students will participate in an 11-week didactic and laboratory-based experiential program on
our Atlanta campus to advance their knowledge of nephrology, urology, and hematology
research through laboratory experimentation, clinical research, career development activities,
responsible conduct in research training, and opportunities to present and share their research.
Specific targeted skills will include data acquisition, analysis and interpretation, and scientific
presentation. The culmination of the summer training will be participation at the NIDDK
sponsored Summer Student Research Symposium. Our overall objective is to train the next
generation of scientists and physician-scientists in nephrology, urology, or hematology research.
Specific Aim 1 is to continue our undergraduate program that garners interest in kidney, urology,
or hematology diseases. Specific Aim 2 is to promote interest in kidney, urology, and
hematology disease research among women and underrepresented minorities. Specific Aim 3
is to increase undergraduate enrollment into PhD, MD/PhD, and MD programs that excel in
nephrology, urology, or hematology research.

Public health relevance
Project Narrative The Summer Undergraduate Program in Emory Renal Research (SUPERR) will provide a research and didactic experience in the study of kidney, urology, and hematologic diseases. Following a national recruitment, the selected students will participate in an 11-week didactic and laboratory or clinical research based experiential program at Emory, culminating with participation in the NIDDK sponsored Summer Student Research Symposium.